Assessing marginal associations between dental caries and periodontal diseases and their determinants in cross-sectional studies

Abstract
This proposed research is both for statistical methodology development and novel secondary analyses of
an important existing national dataset. The overall goal of our proposed research is to assess person-level
marginal associations between dental caries and periodontitis. We consider a modeling setup where
individual units (e.g., teeth and surfaces) are clustered so that the outcomes in a given cluster (e.g.,
mouth) are not independent. Due to the nature of the underlying biology, both caries and periodontal
outcomes are correlated with the size of the cluster. This phenomenon is referred to as “informative
cluster size (ICS).” Additionally, treating a periodontal outcome such as the attachment loss as one of the
two variables in this association study, we may face a greater form of informativeness that goes beyond
ICS; e.g., many more teeth with smaller values than larger values of attachment loss, even for subjects
with comparable numbers for total cluster size (e.g., number of teeth). As a result, a different type of
reweighting will be needed to assess the marginal associations. After developing the general statistical
methodology for calculating these novel associations by solving a generalized estimation equation, we will
apply a regression technique based on jackknife pseudo-values [Andersen et al, 2003] to determine which
of the modeling factors (e.g., sex, race, economic status, family income, smoking status, education level,
tooth position, and so on) significantly contribute to this association.
A motivating dental dataset to which to apply our statistical research is from the National Health and
Nutrition Examination Survey (NHANES). Tooth and surface/site level cross-sectional national US data
stratified by age (30-49, 50-64, and 65+) will be analyzed using our novel statistical methods.
During the proposed research period of two years, we will undertake the following tasks: Aim 1: We will
develop statistical tests based on resampling combined with permutation to test for informativeness of
number of observed data units (e.g., teeth) for caries outcomes at various levels of attachment losses. Aim
2: We will introduce novel inferential methods for the marginal associations (with different
marginalization weights) between caries and periodontal outcomes and those of various covariate effects
and use in detailed analyses of the NHANES data set of periodontal and caries outcomes mentioned
above. Aim 3: We will create a scalable, computationally-efficient, and user-friendly R-package based on
our inferential tools to be developed under Aims 1 and 2. Without this R-package, members of the
scientific community may not be able to our novel methods for their data analysis, since the base R
software does not have implementations of these methods. The R-package will be tested on the NHANES
data set, which will be supplied with this R-package. Finally, the R package will be distributed to the
scientific community at large through CRAN (Comprehensive R Archive Network).
Our proposed research is important both for gaining new scientific knowledge and for statistical
methodology development leading to new tools of data analysis.

Public health relevance
Narrative Both periodontitis and caries are common, yet complex, diseases affecting the oral health of patients. However, their relationships are poorly understood. This proposed research will shed new light on the strength of associations between the two disease outcomes, including identification of factors driving the observed associations. This research will also enrich the statistical literature for analyzing multilevel clustered data exhibiting cluster and sub-group size informativeness.